Regulation of intestinal epithelial barrier function by intercellular junction proteins in health and disease

Abstract
Inflammatory bowel diseases are characterized by intestinal inflammation, increased mucosal cytokines and
compromised epithelial barrier function. Epithelial barrier function is regulated by intercellular junctions that
encompass the tight junction (TJ), adherens junction (AJ) and desmosomes (DMs). It is now evident that
intercellular junctions are highly dynamic structures and their component proteins actively participate in
regulating epithelial homeostasis. Mucosal inflammation compromises epithelial homeostatic properties
thereby resulting in epithelial barrier compromise which contributes to disease pathogenesis. Our knowledge of
the molecular basis of intercellular junction protein cross-talk, epithelial homeostasis and compromised barrier
in intestinal inflammation is however very limited. Thus the overall goals of this proposal are to identify
mechanisms by which intercellular junction proteins control epithelial homeostasis, barrier function and repair
after injury in disease. We will specifically investigate the role of two key intercellular junction proteins,
claudin23 and desmoglein 2 in regulating the intestinal epithelial barrier function and repair after injury. The
influence of inflammatory cytokines on such regulatory processes will be determined. In addition to gaining
insights into the molecular basis of intestinal epithelial barrier regulation, these studies will provide new ideas
for the development of therapeutic agents that strengthen the intestinal epithelial barrier, promote wound repair
and reduce mucosal inflammation. These studies will also provide insight into strategies of transiently
perturbing the epithelial barrier for therapeutic drug/vaccine delivery.

Public health relevance
Project Narrative The epithelial lining of the gastrointestinal tract forms a regulated selective-permeable barrier and controls immune defense, which can be significantly compromised by conditions such as inflammatory bowel diseases, ischemia, mechanical injury and surgical procedures. Epithelial intercellular junctions play a pivotal role in barrier regulation. This proposal seeks to identify the molecular basis by which intercellular junction proteins control barrier function in health and disease, and will also identify how these proteins control repair after injury. Knowledge gained from these studies in the short term will provide a better understanding of basic mechanisms that control epithelial barrier function and wound healing, and in the long term, these studies will aid in the development of new therapeutic strategies aimed at strengthening the barrier and in promoting mucosal wound repair.